Defining human-specific rhombic lip developmental mechanisms

PROJECT SUMMARY
While the human cerebellum is traditionally associated with motor functions, recent studies have implicated the
cerebellum in higher-order brain functions like speech, language, and even satiety. The cerebellum has
dramatically expanded in size across primate evolution so that 80% of human neurons are in the cerebellum.
We have identified several human-specific developmental features that are absent in commonly studied animal
models. These features include spatiotemporally expanded progenitor zones, including the rhombic lip that
produces all cerebellar glutamatergic neurons and an expanded ventricular zone that produces GABAergic
neurons. The human RL is long-lived, present throughout the entirety of gestation and exhibits considerable
structural and molecular substructure; features not seen in rodents and non-human primates. The unique
developmental features of the human cerebellum explains why modeling of human cerebellar developmental
disorders has been challenging. However, by studying human cerebellar development, we have now shown
that defects in rhombic lip development are implicated in human cerebellar malformations associated with
vermian hypoplasia, as well as devastating pediatric brain tumors like Medulloblastoma. Yet, the cellular and
molecular mechanisms that drive human-specific expansion of the cerebellar rhombic lip remain unknown. This
study aims to better characterize this dorsal cerebellar progenitor zone throughout development using a
combination of immunohistochemical and in situ hybridization assays. We will also conduct rigorous spatial
and single-cell transcriptome analyses of this progenitor zones to define the molecular pathways driving its
development. Lastly, we will study the human rhombic lip in the context of cerebellar malformations to identify
aberrant molecular programs contributing to vermian hypoplasia. This study leverages our substantial
expertise of cerebellar development in human and other animal models, together with unique samples of
normal and pathological human fetal tissue obtained from our extensive network of clinical collaborators.

Public health relevance
PROJECT NARRATIVE Our work on the human cerebellum thus far has led to the identification of multiple developmental features that are unique to human and not observed in commonly studied animal models. We have implicated these human-specific features in the pathogenesis of devastating brain birth defects and childhood brain tumors. Yet, a lot more needs to be done to fully understand the cellular and molecular programs driving human cerebellar development, including within the context of cerebellar malformations. The experiments proposed in this grant are designed to improve our understanding of the biology of both normal and abnormal cerebellar development which will enable improved diagnosis and treatment of cerebellar diseases